NAD Metabolism in Aging and Disease: Dysfunction and Intervention

SUMMARY Aging in mammals is complex, with hallmarks including reduced propensity for stem cell self renewal,
deficiencies in DNA repair, reduced responses to growth stimulating hormones and nutrients, metabolic
disruption and increased susceptibilities to the onset of diseases. The origins of the deficits in self renewal, self
repair, and metabolic homeostasis are central questions in the aging field. Arguably, no single factor can be
identified that provides a causative effect. We have focused upon deficits in NAD+ metabolism as a potentially
pleiotropic effector leading to downstream dysfunctions in cellular, tissue and organism health. Processes such
as senescence, which can more readily arise from genetic factors such as defects in DNA repair genes (e.g.
Werner and Bloom Syndromes) present an interesting opportunity to further investigate the role of NAD+
deficiency, given that genetically altered fibroblasts are commercially accessible as potential tools in this regard.
We propose to generally characterize how aging affects NAD+ metabolism in progeroid cells, and in aged mice.
Specifically, we will characterize NAD+ biosynthetic potential as well as rates of NAD+ turnover. Moreover we
will assess how cells respond to pharmacologic interventions that increase NAD+ biosynthesis in order to
determine if these interventions mitigate age-dependent phenotypes in these fibroblast cells. These studies will
provide a deeper view of how NAD+ decline occurs in cells and tissues, and if some cells and tissues are more
susceptible to this decline than others and why. A second part of the application focuses on the discovery of a
novel NAD+ enhancer called dihydronicotinamide riboside (NRH), which can raise NAD+ concentrations from 3-
10 fold in mammalian cells. Preliminary data shows that NRH uses a novel mechanism of action,wherein it is
converted to NMNH, independent of the known kinases Nrk1 or Nrk2, leading to biosynthesis of NAD+. In mice
this compound increases NAD+ concentrations many-fold over control in most tissues. This application
investigates its mechanism of action in fibroblasts and in mice to elucidate a novel biosynthetic pathway to NAD+
with translational potential for treatment of disease. Thus, in the latter part of the application, we characterize
NRH effects in aged mice and ascertain if it can induce mitochondrial biogenesis. We provide studies to
characterize its effects using metabolomics approaches. Finally we test NRH to treat a model of metabolic
syndrome and to characterize the effect of age on disease and treatment outcomes. The objectives of the grant
are accomplished via 3 specific aims: 1. To characterize NAD+ homeostasis in cells and mice as a function of
age. 2. To elucidate effect and metabolic pathway of NRH in fibroblasts and mice. 3. To determine the effect of
NRH on aged mice in altering NAD+ metabolism, mitochondrial biogenesis and mitigation of a model of metabolic
syndrome. The accomplishment of the objectives will provide new understanding of how NAD+ is a key factor in
aging and whether next generation NAD+ precursors can alter phenotypes that are hallmarks of aging.

Public health relevance
Narrative: This grant proposes to elucidate how aging affects NAD+ metabolism in normal and progeroid fibroblasts as well as in mice, and if NAD+ replenishment can mitigate progeroid or senescence phenotypes. A second aspect of work characterizes the effect and metabolic pathway of a novel NAD+ precursor called dihydronicotinamide riboside (NRH) in fibroblasts and mice. Finally, pre-clinical translational studies characterize effects of NRH in eliciting mitochondrial biogenesis in aged mice and test its effects in the treatment of a mouse model of metabolic syndrome.